Integrating Epigenetic Modulation into DNA Damage Repair

Screening for hereditary DNA repair mutations in cancer has accelerated as Homologous Recombination Repair
(HRR) deficient tumors respond well to DNA damaging agents and poly (ADP-ribose) polymerase inhibitors
(PARPi). The most common HRD mutations include BRCA1, BRCA2, ATM, and CHEK2. Such mutations convey
a 40-80% lifetime breast cancer risk across all racial and ethnic backgrounds, and pose elevated risks for
ovarian, prostate and pancreatic cancer. While less toxic, responses to PARP inhibitors are still often short,
despite a high initial response rate. Efficacy of PARP inhibitors in ATM and CHEK2 is mechanistically expected,
but not yet established. Overlapping toxicities have significantly challenged the ability to combine PARPi with
chemotherapy, and immunotherapy combinations remain of limited benefit in most breast cancer subtypes.
In a quest to enhance PARPi efficacy, we studied strategies to increase DNA trapping and inhibition of DNA
repair. DNA methyltransferases (DNMTs) directly modulate the DNA repair pathway and work in complex with
PARP to repair single strand DNA breaks. As such, we hypothesize that DNMT inhibition would significantly
improve the therapeutic benefit of PARP inhibition in HRD cancer. We found enhanced PARP trapping and
promising synergistic efficacy with very low doses of the DNMT inhibitor, decitabine, and PARPi in preliminary
in vitro and in vivo studies which was significantly enhanced in genetically engineered HRR mutated cancer cell
lines and PDX models. Responsiveness to the combination varied by tumor (sub) tissue context and select HRD
gene mutation. Preliminary data form our work has led to the approval of a dose finding phase I trial sponsored
by the Alliance Network (A092003). In this application, we will explore biomarkers and mechanisms of sensitivity
and resistance to combination PARP and DNMT treatment to provide deeper mechanistic insights and guide
patient selection in the provisionally-approved large randomized ComboMatch trial (EAY191 A4) in three aims.
Aim 1: Determine the mechanism of synergy and comparative effects of combined PARP and DNMT
inhibition in isogenic cell lines bearing targeted mutation of 4 different HRR pathway genes, in vitro, in xenografts,
and in comparison to established PDX with similar HRR mutations but different genetic backgrounds.
Aim 2: Use pre- and posttreatment tumor biopsy and serial blood samples from patients in the Phase I
Alliance Network (A092003) trial to generate a detailed understanding of patient’s HRR mutation, accompanying
genomic landscape, and functional status of the HRR pathway. Establish Patient Derived Xenografts (PDX) from
biopsy specimens for work in Aim 3 regarding resistance mechanisms. Assess circulating tumor DNA (ctDNA)
for predictive biomarkers of therapeutic response.
Aim 3: Translating from the clinic back to the bench, test the veracity of the therapeutic responses in PDX and
organoid models compared to the source patient responses, identify PARPi+DNMTi therapeutic resistance
mechanisms, test sensitivity to potential followup therapeutics.

Public health relevance
PROJECT NARRATIVE/RELEVANCE BRCA mutations confer an over 70% lifetime risk for breast cancer and the approval of several poly (ADP-ribose) polymerase (PARP) inhibitors have brought new hope for patients with homologous recombination repair deficient (HRD), including BRCA1/2-mutated breast, ovarian, prostate and pancreatic cancers. The combination of epigenetic modulators, such as DNA methyltransferase inhibitors, with PARP inhibitors may help the considerable number of patients who are or become refractory to these agents by exploiting the DNA vulnerability of BRCA and other HRD-mutated tumors.